Dried blood spot proteomics analysis of newborn screening cards to identify prognostic markers of SIDS risk

PROJECT SUMMARY
Despite fewer deaths as a result of the Safe Sleep campaign, the Sudden Infant Death Syndrome (SIDS) remains
the leading cause of post-neonatal infant mortality in the United States (0.33/1000 live births). Our research
strongly implicates biological abnormalities within the brainstem that underlie an infant's vulnerability to SIDS.
We have also identified SIDS-associated abnormalities within the serum and platelets taken from SIDS victims
at autopsy. Together, these data suggest molecular abnormalities in the blood and brain of SIDS infants at death.
What is unknown, however, is to what extent abnormalities observed at autopsy are also present at birth, and
whether these or other, yet to be discovered, abnormalities can identify SIDS risk during the neonatal period,
thereby providing the opportunity for intervention. Although there are no known biomarkers for SIDS risk, reports
of apnea, cardiac rate abnormalities, and arousal deficits in infants who subsequently die of SIDS support the
possibility that an underlying vulnerability may exist in the infant subclinically. Such subclinical abnormalities then
manifest themselves when the infant is sufficiently stressed during a critical developmental period. Our laboratory
has now acquired a unique dataset of dried blood spots (DBS) from neonatal screening cards from infants who
later died of SIDS (n=109), died of known causes of death (demise controls, n=34), and age- and sex-matched
control infants, identified as healthy at birth based on newborn screening for metabolic disorders (healthy controls
(n=60)). In addition, we have corresponding brainstem tissue from autopsy in ~50% of these SIDS and demise
control infants. Utilizing this dataset, we hypothesize that infants dying of SIDS display at birth abnormal protein
profiles in DBSs compared to controls. Using liquid chromatography/mass spectrometry (LC/MS), we will test
this hypothesis by performing an unbiased proteomic analysis of DBSs from SIDS and control infants (Specific
Aim 1). Using the matching brainstem tissue we will use targeted methodologies, such as Western blotting,
immunohistochemistry, and/or RNAscope to address the question of whether putative blood protein
abnormalities at birth are represented in brain tissue collected at autopsy (Specific Aim 2). The use of neonatal
DBSs for unbiased proteomics in SIDS is novel and the data generated from this unprecedented sample
collection has potential to identify yet unknown proteins and/or pathways that play a role in SIDS pathogenesis.
Furthermore, these data will allow us to assess identified abnormalities for their predictive potential for SIDS
death and therefore their potential as neonatal biomarkers of SIDS risk. Given our overall goal, this application
is fully aligned with NICHD's recent notice of special interest (NOT-HD-21-032) focused on identifying the root
cause of SIDS with the aim to reduce SIDS-related deaths. The data to be generated from this R21 will provide
novel prognostic information about SIDS infants at birth which will then be utilized as pilot data to expand upon
in an R01 with new hypotheses, larger newborn datasets, and animal models.

Public health relevance
PROJECT NARRATIVE In the U.S., the Sudden Infant Death Syndrome (SIDS) is a leading cause of death in the first year of life for which there is no indication or prognostic biomarker of SIDS risk to enable intervention. We have acquired a unique dataset with neonatal dried blood spots (DBSs) and corresponding autopsy brain tissue from infants dying of SIDS and other known causes of death (controls). We propose unbiased and targeted proteomics in the DBSs and brain tissue, respectively, with the goal of identifying proteins and/or pathways that can be used as prognostic biomarkers of SIDS risk and/or biomarkers of global (blood and brain) abnormalities that underlie SIDS vulnerability.